Hazardous Materials Worker Health and Safety Training

? DESCRIPTION (provided by applicant): As a 501 (c) (3) not-for-profit institutions created for the sole purpose of improving working conditions in the U.S. construction industry, CPWR's mission aligns with the goals of the NIEHS Worker Training Program (WTP). CPWR's purpose as an organization, as stated in its Articles of Incorporation are; to encourage the elimination o reduction of conditions constituting hazards to the health or safety of workers, and to promote the maintenance and improvement of safe and healthy working conditions for workers. Beyond these broad, long-term objectives of CPWR as an organization, the specific aims of this proposed training program are: 1) to train 9,535 students in 620 courses over a five year period, and to continue instructor development through annual Train-the-Trainer programs and Instructor Enhancements (HWWTP); 2) to train 300 minority workers over a five year period in three cities (New Orleans, LA; St. Paul, MN; and East Palo Alto, CA) and place at least 80% in construction union apprenticeship training programs for jobs in the construction and environmental remediation industries (EWCTP); 3) to directly train 1,815 additional Outreach Instructors in the disaster program over a five year period, while partially supporting more than 4,800 additional Outreach Instructors, and to continue to work with NIEHS, other grantees, and OSHA in moving the training forward as part of our collective efforts to increase preparedness in the U.S. construction industry to respond to large scale natural and man-made disasters (HDPTP); and 4) continue rigorous evaluation over the five year period to continuously assess training effectiveness of all three programs. To achieve these aims, CPWR submits this application in coordination and cooperation with a training consortium of 11 international/national building trades unions representing workers engaged in hazardous waste work at designated 1910.120 sites around the country and in other environmentally hazardous work assignments. Our proposed program is therefore national in scope, with our building trades union training consortium representing more than 3 million construction workers geographically dispersed throughout every state in the nation. CPWR's building trades union training consortium is diverse, with each of our 11 partnering unions representing workers that apply different skills necessary on environment remediation sites. Typical of the cyclical, transient nature of the industry and its workforce, our target population of workers move on and off environmental remediation sites, often moving from one employer to another. The HWWTP application in this application describes in detail the types of jobs workers represented by each of our 11 consortium partners perform on designated 1910.120 sites. Whether they work on these sites for years, months, weeks, or just a few days, with the support of this proposed program CPWR and its 11 consortium partners aim to assure these workers are adequately trained to protect themselves, their co-workers, and their environment.

Public health relevance
PUBLIC HEALTH RELEVANCE: The relevance of this application on public health is for the construction worker population to become a safer and healthier collective group. A safer, healthier construction worker collective population can reduce the number of injuries and fatalities to workers which bring hardship to their families, communities and employers.